Exploring predictors of response to a peer-mediated communication intervention for minimally verbal preschoolers with ASD

PROJECT SUMMARY
This R21 proposal will explore and examine individual child social variables that predict response to a peer-mediated intervention for preschoolers with autism spectrum disorder (ASD) and limited to no spoken
communication. This subgroup of children with ASD present with a myriad of social and communication
challenges that restrict participation in educational and social environments, and approximately 30% remain
minimally verbal by the time they reach kindergarten. Peer-mediated interventions (PMIs) are a widely-used
and evidence-based approach to teach social communication to young children with ASD. Recent reports
have documented the benefits of incorporating augmentative and alternative communication (e.g., speech-generating devices) into PMIs to increase communication and social interactions with peers in inclusive
setttings. Children's social competence with peers is considered a fundamental developmental process that
contributes to later language, social-emotional development, and academic achievement. To date, we are not
aware of studies identifying specific child variables that predict child response to PMIs. There is evidence of
differences in social attention (i.e., visual attention/scanning of social stimuli) for children with ASD compared
to typically-developing children. It is probable that among individuals with ASD, variability in performance on
measures of social attention (i.e., visual attention to the face) and interest in peers (i.e., showing joint
attention and imitation) may be important predictors of response to PMIs. Measuring proximal behaviors such
as social attention and peer interest moves beyond prior efforts focusing on more global child variables (e.g.,
cognitive skills) and should allow for identifying those children who require tailoring of PMIs. The overall
objective of this innovative study is to examine potential child variables that predict response to PMI for
preschoolers with ASD (n=40) with limited to no spoken communication. Two peers without disabilities will be
paired with each child with ASD (n=80 peers). All children will participate in a PMI developed and examined
by the PI over a series of empirical studies. The specific aims are to: determine what social variables (i.e.,
social attention and peer interest) predict response to the PMI at 8 weeks post-treatment and in generalization
probes, and to determine if variance in child communication gains, accounted for by the social variables,
differs based on the pre-treatment measurement context (i.e., semi-structured peer assessment, naturalistic
observations, and eye-tracking paradigms). The team is highly qualified to accomplish these aims as
investigators have developed social interventions for children with ASD, created observational methods to
assess child-peer communication, and have used eye-tracking technology to measure early attention and
communication. Expected outcomes could have important clinical implications for optimizing PMIs (e.g., for
children who have poor social attention and peer interest), and identifying stratification variables that could be
incorporated into future intervention research for an understudied group of children with ASD.

Public health relevance
PROJECT NARRATIVE Results of this study have the potential to increase knowledge on specific variables (i.e., social attention and peer interest) that predict treatment response to peer-mediated intervention (PMI) for a subgroup of preschool children with ASD and limited to no spoken communication. Examining child behaviors that predict gains in communication with peers and the influence of the assessment context on child outcomes may shed light on why PMIs are more effective for some children with ASD than others, and what is needed to optimize child treatment response and generalized communication behaviors with peers.